Simulation for Environmental Exposure Education (S3E): A Serious Game Platform for Environmental Health Literacy

ABSTRACT: Simulation for Environmental Exposure Education (S3E)
Studies have documented cumulative health effects of chemical and nonchemical exposures on children that
can impact them for a lifetime. In-home environmental exposure risks are particularly impactful on health
because children spend 80-90% of their time indoors, and impact disproportionately falls on disadvantaged
youth. These environmental exposures have been shown to increase inflammation, asthma, lead poisoning,
cancer and a host of other conditions. In addition, just a subset of these environmentally mediated diseases in
US children is estimated to cost $76.6 billion per year. To provide the knowledge and skills to address these
challenges and to inspire awareness and action, young people need to develop their environmental health
literacy. This project proposes to do that through the design and pilot testing of a mobile serious game, S3E, to
improve environmental health literacy among middle-school age youth by scaffolding learning and
communication about toxic environmental exposures occurring at home. The game will be built using a 2.5D
platformer-style architecture with a simulation of socio-physical dynamics. Players will: 1) Design the physical
and social environments of their own simulated world, including everything from using 360 degree scans from
their own home to designing their ultimate fantasy space; 2) Add, remove, and modify objects that impact
environmental exposure; 3) Move, interact, communicate, and take action in a virtual experience to avoid
environmental exposure and sickness, injury, or death. As the player moves throughout the game, they will have
access to data about the environment. The game will have embedded real-time displays that inform students of
simulated sensor readings for contaminant levels in air, water, soil, surfaces, and bodies of humans and pets.
Increasing adverse health in response to these contaminants is represented by animated acute symptoms in
players and non-player characters (family, pets, etc.), such as dizziness, nausea, coughing, difficulty breathing,
or unconsciousness. In the process of playing the game, students will discover personalized solutions to reduce
exposure (opening a window, removing a heater, etc.) and build models and mechanisms of environmental
exposure. The content will be aligned with Environmental Health Literacy and Science and Engineering practice
in the Next Generation Science Standards to facilitate integration of the game into formal educational settings.
In Phase I of the project, we will conduct formative research with youth aged 11-13, including focus groups,
interviews, and recruiting a diverse panel to co-design the game, develop a portion of the game using two
exposure risks–secondhand/thirdhand smoke and carbon monoxide poisoning–and play test and pilot test the
game to evaluate usability, playability, and impact on knowledge and intentions around environmental risk in the
home. Phase II will complete game development with the addition of more features and more exposure risks and
conduct a randomized clinical trial to assess the impact of the game on environmental health literacy and action.

Public health relevance
PUBLIC HEALTH NARRATIVE Exposure to environmental toxins in the home has a detrimental impact on the health of children. Environmental risk includes such things as mold, smoke, lead, radon, carbon monoxide, and many others. These types of environmental exposures have been shown to increase the rate of many health conditions, including inflammation, asthma, lead poisoning, and cancer. The cost of just a subset of environmentally mediated disease in US children is estimated to cost more than $76 billion per year. This research will develop a series game to be played on mobile devices that will improve the health literacy of youth. The game, if effective, will increase their knowledge and understanding of environmental risks and spur them to take action to reduce their risk and the risk to others. This will ultimately reduce the impact of environmental exposure in the home leading to healthier children and a healthier population overall.